Vitamin B6 Modulates NK Cell Metabolism in Pancreatic Cancer

Project Summary: The poor survival rates in pancreatic ductal adenocarcinoma patients are in part due to poor
response to existing therapies. Thus, there is an urgent need to develop novel therapies. NK cell-based therapies
present a promising option because NK cells primarily target tumor cells through direct killing or IFN-gamma
production and are not dependent on MHC expression. However, in the tumor microenvironment, NK cells
directly compete with tumor cells for nutrients to maintain basal cellular metabolism. Of note, cellular metabolic
pathways are closely linked with the effector response of NK cells. Tumor-educated NK cells demonstrate
increased glycolysis, which potentiates their cytotoxic activity. However, the complete spectrum of metabolic
reprogramming in NK cells is not fully understood. Pancreatic tumors are highly glycolytic. The tumor cells exhibit
constant high demand for glucose or glutamine to fuel the anabolic needs and exhaust the essential nutrients in
the tumor microenvironment milieu. Nutrient starvation triggers metabolic alterations to support proliferation and
the aggressive phenotype of pancreatic tumors. Hence, the pancreatic tumor microenvironment displays nutrient
paucity, which restricts the metabolic flux in NK cells. Our preliminary data suggest the scarcity of vitamin B6 in
NK-tumor cell co-cultures becomes a limiting factor for the anti-tumor response of NK cells against pancreatic
tumor cells and organoids. Furthermore, vitamin B6 paucity and glucose-limitation induce metabolic rewiring in
NK cells to sustain glycolysis and downstream metabolic pathways. Of note, tumor progression causes a
systemic imbalance of vitamin B6. We observed a significant reduction in systemic vitamin B6 metabolites in
PDAC patients. Moreover, we demonstrate that pancreatic tumor cells display increased metabolic flux and
dependence on metabolic pathways that are dispensable for NK cells, providing a metabolic vulnerability that
can be targeted in combination with vitamin B6 supplementation. Taken together, we posit that pancreatic tumor
cells exhaust vitamin B6 in the tumor microenvironment milieu, impacting cellular metabolism and inducing NK
cell dysfunction. We will examine (Specific Aim 1) the metabolic pathways that favor tumor cell-mediated vitamin
B6 exhaustion in the PDAC TME milieu to sustain tumor cell proliferation under nutrient-limiting conditions. In
Specific Aim 2, we will investigate the functional significance of vitamin B6-induced metabolic remodeling in
NKs that regulate the anti-tumor response of NK cells in 2D cultures, organoids, and orthotopic mouse models.
We will also examine the therapeutic potential of targeting the selective metabolic dependencies of tumor cells,
in combination with vitamin B6 supplementation, in the context of nutrient limitation in the tumor
microenvironment in orthotopic and patient-derived xenograft models (Specific Aim 3). Overall, our study will
investigate the metabolic competition between pancreatic cancer cells and NK cells for understanding the
selective metabolic vulnerabilities for developing robust NK-based therapies in the long run.

Public health relevance
Project Narrative In pancreatic tumors, while nutrient-restrictive milieu governs NK cell exclusion and dysfunction, tumor cells sustain their growth through metabolic adaptations. This study will investigate the impact of vitamin B6 limitation in the tumor microenvironment on NK cell metabolism and function, with a parallel focus on targeting vitamin B6- dependent growth in tumor cells.